BCCMA: VA Colorectal Cancer Clinical & Computational Collaborative (VA-5C): NIR-labeled antibodies to target and label colon polyps and cancer for improved diagnosis and surgery

Colorectal cancers comprise the third most common cause of cancer-related death in the US and are major
causes of death in the Veteran population. For colorectal cancer, early detection and complete surgical resection
of tumors are critical to patient outcomes. The present application aims to develop a tumor-targeting fluorescent
antibody that will specifically label premalignant polyps and primary and metastatic colon cancer to increase the
accuracy of diagnosis and treatment and improve outcomes. With their unique properties, anti-mucin antibodies
show great promise as targeting moieties in molecular imaging and therapy. Their fast blood clearance, rapid
and homogenous tissue penetration, and low background retention allow highly specific imaging at early time
points after administration and effective therapy with minimal nonspecific toxicity, as demonstrated by our
published feasibility studies. Our published feasibility experiments have demonstrated that near-infrared (NIR)
fluorophore-labeled antibodies against tumor-specific antigens will improve visualization, detection, resection,
and outcome of colorectal cancer in genetically engineered mouse models (GEMMs) and patient-derived
orthotopic xenograft (PDOX) mouse models, which mimic the clinical behavior of cancers. The present
application will accomplish the necessary experiments for the NIR-labeled antibodies to be ready for clinical
development. Our proposal has the following aims: 1) NIR-labeled antibodies will be evaluated and compared
to control antibodies for their ability to target and illuminate premalignant colon polyps in GEMMs for fluorescence
colonoscopy and 2) NIR-labeled antibodies will be evaluated and compared to control antibodies for their ability
to target and illuminate primary and metastatic colon cancer in PDOX models for fluorescence-guided surgery
(FGS). Achievement of the goals of this application will establish fluorescent tumor-specific antibodies that
brightly label tumors and metastases in patient like mouse models of colorectal cancer that are demonstrated to
be effective for FGS. Therefore, by the end of the funding period, the NIR-labeled antibody will be used ready
for clinical development. The fluorescent-labeled tumor-specific antibodies developed in this application will be
used to improve the outcome of the Veteran population with colorectal cancer.
Grant application features:
· Tumor-specific anti-mucin antibodies for labeling of premalignant polyps and colorectal cancer
· Very bright tissue penetrating NIR dyes
· PDOX mouse models targeting recalcitrant colorectal cancer
· Near-infrared fluorescence guided colonoscopy and surgery

Public health relevance
In the present proposal, we will develop tumor-specific near-infrared fluorescence labeling of premalignant polyps using genetically engineered mouse models (GEMMs) and primary and metastatic colorectal cancer using novel patient-derived orthotopic xenograft (PDOX) models and improve the outcome of cancer surgery. We will validate tumor-specific anti-mucin antibodies for their ability to brightly label tumors to remove them at the time of surgery more effectively. We will evaluate long wavelength dyes with increased penetration depth and ability to detect the smallest tumor deposits and provide the highest tumor-to-background ratios and specificity compared to dyes in the visible range. We will utilize near-infrared fluorescence-guided surgery (FGS) to improve surgical outcomes for colorectal cancer and liver metastases in PDOX mouse models. The completion of these aims will set the stage for clinical trials of fluorescent anti-mucin antibody-based FGS that can change the paradigm of cancer surgery and greatly improve outcomes of recalcitrant cancers.